The representation of human odor in the mosquito brain

Summary
Mosquitoes transmit pathogens that are a major worldwide health problem. Over 500,000 deaths are caused
by mosquito-borne diseases annually. Aedes aegypti mosquitoes are arboviral vectors that transmit the
pathogens that cause Dengue, Zika, and other illnesses. Only female mosquitoes bite, and they do so to obtain
the nutrients required to reproduce. To find humans to bite, female mosquitoes must integrate multiple sensory
cues. To find humans, they rely heavily on human body odor, which is composed of hundreds of chemicals,
and carbon dioxide emitted in breath. The study of the mechanisms that mosquitoes use to detect odorant
chemicals and carbon dioxide have been focused on the peripheral sensory neurons that detect odorants and
other sensory cues. It is essential to move beyond the sensory periphery and study the central nervous system
because mosquitoes use redundant sensory cues to detect humans: mutant mosquitoes lacking key receptors
can still find humans, highlighting this system’s robustness and the importance of studying it holistically in order
to disrupt biting. Almost nothing is known about the neurons that are downstream of the olfactory sensory
neurons in Ae. aegypti, including how sensory cues converge, and what circuit mechanisms make the
mosquito olfactory system so resistant to perturbation.
The olfactory system of Ae. aegypti mosquitoes provides a rare opportunity to study fundamental
questions about olfaction while also solving an urgent biomedical question. The goal of this work is threefold:
1), to identify which neurons encode human odor in the mosquito brain, 2) determine how olfactory information
converges to guide human host seeking, and 3) identify circuit mechanisms that combine information about
odor and carbon dioxide. To achieve these goals, we will develop new techniques to study the mosquito central
nervous system. Trans-synaptic labelling is a fundamental approach used in neuroscience research because it
can identify synaptically connected neurons, thereby enabling the study of interconnected neurons in a circuit
or pathway. Currently, there are no methods for trans-synaptic labelling in non-model insects, including Ae.
aegypti. We will develop a method for trans-synaptic labelling in Ae. aegypti based on the trans-tango system
used in Drosophila melanogaster. Using this approach, we will generate transgenic mosquito strains to
examine the anatomy, activity, and the transcriptional profile of targeted neurons. We will use these essential
neuroscience methods to study the central circuits that detect human odor and ultimately drive host seeking
behavior. This will lay the groundwork to develop new strategies to intervene in mosquito biting and also add to
our fundamental understanding of the circuits that underly olfactory-driven behaviors.

Public health relevance
Narrative Mosquito-borne disease is a major threat to global public health, resulting in more than half a million deaths every year. A greater understanding of how mosquitoes detect humans would allow us to develop novel strategies to intervene in mosquito biting behavior and disease transmission. The proposed projects will develop new genetic methods to study key components of the central nervous system of Aedes aegypti mosquitoes and apply those techniques to understand how mosquitoes combine multiple cues during the search for a person to bite.